Multi-Ancestry Genome-wide Association Analysis and Polygenic Risk Score of Moderate-to-Severe Asthma

PROJECT SUMMARY
Moderate-to-severe asthma represents 10 to 15% of all asthma cases but accounts for most of asthma-related
costs and is associated with more life-threatening exacerbations than mild asthma. Environmental and genetic
factors both contribute to asthma and the influence of genetics has been suggested to be as high as
70%, depending on the phenotype. Recent genome-wide association study (GWAS) evidence suggests that
there are genetic variants specifically associated with moderate-to-severe asthma but not mild asthma
such as the rs11603634 in MUC5AC which regulates mucin production. However, the previous GWAS
were conducted exclusively in European ancestry individuals, despite non-European ancestry populations
having higher risk of moderate-to-severe asthma. The goal of this project is to identify the genetic variants
specifically associated with moderate-to-severe asthma compared to mild asthma in multi-ancestry and
ancestry-specific GWAS and to develop and evaluate polygenic risk scores (PRS) predictive of the asthma
subtype. We will use the National Institute of Health (NIH) All of Us Research Program (AoURP), an ongoing
prospective cohort that has available data on 413,350 adult participants to date, of which 249,740 with array
genotyping data provided access to their electronic health records. Using the Systemized Nomenclature of
Medicine (SNOMED) and the 10th international classification of diseases (ICD-10) codes, we identified 6,251
moderate-to-severe asthma cases and 17,085 mild asthma controls. In moderate-to-severe asthma, the
ancestries of the participants were 53.0% for European ancestry, 23.5% for African, 16.9% for Hispanic/
Latino and 6.6% for Other. Our specific aims will be 1) to determine the multi-ancestry and ancestry-
specific genetic variants associated with moderate-to-severe asthma and 2) to develop and validate PRS
predictive of moderate-to-severe asthma among asthmatics. In Aim 1, we will conduct the GWAS on 80% of
AoURP participants with moderate-to-severe and mild asthma and perform fine mapping to identify genetic
variants most likely causal. In Aim 2, we will develop and evaluate the PRS in the 20% AoURP participants
remaining from Aim 1 and validate them in the UK Biobank as well as the Greater Cincinnati Pediatric Clinic
Repository (GCPCR). This innovative project will be the first multi-ancestry GWAS on moderate-to-severe
asthma. Upon completion, we will have determined the specific genetic variants, provided insights into the
potential distinctive mechanisms and developed predictive PRS for this asthma subtype.

Public health relevance
NARRATIVE Moderate-to-severe asthma affects 10 to 15% of asthmatic patients but accounts for over 50% of the healthcare cost. It affects all racial/ethnic groups, but has a higher burden in minority populations which have been absent from the previous genome-wide association studies of this asthma subtype. Therefore, it is of public health importance to identify genetic variants associated with moderate-to-severe asthma and to develop polygenic risk score that will allow for disease prediction in multi-ancestry and ancestry-specific populations.